Complement C1q and sepsis associated fatalities

PROJECT SUMMARY
Sepsis is a life-threatening systemic inflammatory condition with dysregulated host responses to an infection.
Although key hyperinflammation-based organ dysfunctions that drive disease pathology have been discovered,
the syndrome is often difficult to recognize, and current published prognostic criteria poorly identify those
destined to die with the condition. Continued failure of our efforts in improving disease prognosis in sepsis is
mainly due to substantial heterogeneity in the patient response. Even with similar age, sex, and medical
comorbidities, there is a substantial heterogeneity in the patient mortality despite excellent supportive efforts.
Here, (1) we discovered that a subpopulation of CD49c+ neutrophil arising in critically ill patients independently
predicts mortality from sepsis. (2) We further found that the neutrophil subpopulation associated with septic
fatality dramatically upregulated gene expression of the complement component C1q. (3) Importantly,
neutrophils from septic survivors expressed higher levels of C1q protein, while deceased patients failed to
maintain C1q expression in their neutrophils. (4) In mouse sepsis models, blocking C1q with neutralizing
antibodies or conditionally knocking out C1q in neutrophils led to a significant increase in septic mortality. (5)
Treatment of septic mice with C1q drastically increased the survival. Based on these preliminary observations,
our overarching hypothesis is that neutrophil C1q is a reliable prognostic biomarker of septic mortality. It
is hypothesized further that apoptotic neutrophils release C1q to control their own clearance in critically
injured organs during sepsis. Thus, C1q is a druggable target for attenuation of inflammatory damage
to septic patients with resulting improvement in survival. In Aim 1, we will determine the correlation between
C1q expression in peripheral blood neutrophils and sepsis mortality in ICU patients. Aim 2 will investigate the
mechanisms by which C1q regulates the resolution of sepsis, including C1q-dependent phagocytosis of
apoptotic neutrophils and differentiation of macrophages. Aim 3 will investigate mechanisms underlying the
heterogenous C1q expression. Aim 4 will determine the effects of recombinant C1q and its mutant variants on
the survival of septic mice. Taken together, this proposal addresses mechanisms regarding how the dysregulated
host response threatens patient survival and offers a molecular target for dampening the destructive arms of the
hyperinflammatory response while promoting disease resolution and tissue recovery.

Public health relevance
PROJECT NARRATIVE Severe sepsis, defined as sepsis associated with acute organ dysfunction, is an increasing cause of morbidity and mortality among children and adults, and has been one of the most significant challenges in critical care. This study will determine the underlying mechanisms that lead to the accumulation of neutrophils in the organs that causes fatal hyper-inflammatory responses in septic patients. Understanding how to control tissue damage through manipulation of neutrophil resolution has potential applications in many acute/chronic inflammatory settings including sepsis.